Estimating Impacts of Social Safety Net Generosity on Neglect and Physical Abuse in Young Children

Summary
Approximately 1 in 3 children in the US experience neglect and/or abuse (“maltreatment”) before they turn 18
years old, with marginalized racial and ethnic communities and young children facing the greatest risks. For the
past century, research has treated maltreatment largely as a failing of individual parents, despite robust
evidence that maltreatment risk, particularly for neglect and physical abuse, is powerfully shaped by structural
determinants such as poverty and stress. Population-level maltreatment prevention could have major public
health impacts, but it is not yet clear how to prevent maltreatment at scale. Emerging research suggests that
economic and social welfare policies that alleviate financial hardship and reduce stressors for families could
potentially serve as population-level prevention interventions. However, two major gaps limit the utility of the
existing evidence base for identifying policies with the potential to prevent maltreatment. First, prior research
has evaluated individual policies one at a time without accounting for the ways that changes in one safety net
policy may affect the eligibility for and benefits from others. This failure to account for policy interactions may
result in mis-estimation of overall safety net benefits and mis-attribution of effects of one policy to another.
Second, prior research has almost exclusively assessed maltreatment through Child Protective Services (CPS)
involvement (e.g., reports of maltreatment to CPS), and thus impacts on other critical public health outcomes
such as maltreatment-related injuries remain unknown. The overarching goal of this research is to identify the
impact of social safety net policies on CPS reports and injuries related to neglect and physical abuse in young
children. Two key innovations will directly address current knowledge gaps. First, to estimate benefits from
each major social safety net program (EITC, CTC, SSI, TANF, SNAP/WIC, and Medicaid/CHIP), accounting for
other programs, we will use and expand a safety net benefits calculator. This calculator sequentially applies
program rules for each state and year, allowing benefits from one program (e.g., TANF) to be incorporated into
eligibility and benefits estimates for others (e.g., SNAP), as dictated by program rules. Second, we will
combine and harmonize over 300 state-years of data on ED and inpatient visits for pediatric injuries that are
highly correlated with maltreatment. We will estimate the impact of social safety net policies on these
maltreatment-related injuries in addition to CPS reports. We will focus on young children (aged <5 years) as
they are at greatest risk of maltreatment. We will also examine these outcomes by race and ethnicity to
determine impacts on equity. The aims of our research are to: (1) Estimate the effect of major social safety net
policies (EITC, CTC, SSI, TANF, SNAP/WIC, Medicaid/CHIP) on CPS reports of neglect and physical abuse in
young children (age <5 years), overall and by race and ethnicity; and (2) Estimate the effect of major social
safety net policies (EITC, CTC, SSI, TANF, SNAP/WIC, Medicaid/CHIP) on neglect- and physical abuse-
related hospitalizations in young children (age <5 years), overall and by race and ethnicity.

Public health relevance
Narrative Population-level maltreatment prevention could significantly improve public health, but it is not yet clear how to prevent maltreatment at scale. The proposed project will estimate the potential for major social safety net policies (EITC, CTC, SSI, TANF, SNAP/WIC, and Medicaid/CHIP) to prevent neglect and physical abuse in young children. To accurately and comprehensively identify the policies with the greatest potential impact, the project will measure and account for the ways that policies interact with one another and examine effects on both maltreatment-related injuries and Child Protective Services reports.